Research Development Core

PROJECT SUMMARY / ABSTRACT RESEARCH DEVELOPMENT CORE
Understanding the complexity of the aging process and its profound effects across all levels of biological
organization will require a strong, interdisciplinary, and diverse supply of talented scientists. The overall goal of
The Jackson Laboratory Nathan Shock Center (JAX NSC) Research Development Core is to provide support
for the career development of junior faculty entering the field of basic aging biology or other investigators who
wish to change career direction toward basic aging research. During the current funding period, the JAX NSC
Research Development Core competitively awarded funding and resources to aging projects using the mouse
as a biological system. These projects resulted in new discoveries, research publications and sources of funding,
and helped junior awardees establish their own independent careers in aging research. Moving forward, these
successes will be expanded by providing targeted funding to exciting projects proposed by investigators new to
aging research, and by offering a variety of research and intellectual resources to support awardees and other
investigators in their work. The outstanding institutional resources available at JAX, a premier institution for
mouse genetics and systems biology research, will be leveraged to sustain and grow this foundation of
researchers at JAX and within the aging community. The Specific Aims of this Core are: Aim 1. Provide support
for projects by new investigators in aging research using a competitive pilot award program. Promising
investigators new to aging research will be funded through a competitive process so they can generate the data
and gain the expertise necessary to support competitive funding applications and a transition to a career in aging
biology. Aim 2. Provide resources to support pilot awardees and investigators new to aging research.
Access to resources (e.g., aged mice, data, tissues, phenotype platforms, expertise) will be provided to support
pilot awardees and other investigators new to aging research. The aged mouse cohorts and phenotyping
technologies supported by the JAX NSC present a valuable opportunity for investigators to access material and
collect data that might otherwise be prohibitively expensive or difficult to obtain. Aim 3. Provide mentorship,
training, and career development opportunities in aging research. Investigators new to aging research will
be provided with mentorship by JAX NSC researchers and collaborators. They will also be given opportunities
for career development in the aging field via support with the grant writing process, opportunities to participate
in aging meetings, and introductions to potential collaborations within the broader geroscience community. The
Research Development Core will have a significant impact on the support and expansion of the pool of
investigators devoted to the study of the basic biology of aging.